Evaluating the effectiveness of the Common Elements Treatment Approach (CETA) in Peru: Mechanisms of individual and intergenerational change

PROJECT SUMMARY/ABSTRACT
Recent advances in intervention research have revealed the promise of transdiagnostic, modular approaches
implemented by lay paraprofessionals for the treatment of the most prevalent mental health concerns in
settings affected by adversity (e.g., anxiety, depression, posttraumatic stress), but to date, few effectiveness
trials have examined the indirect effects of treatment on intergenerational and economic outcomes or
moderators of treatment effectiveness. There is thus a critical need not only for the continued expansion of the
evidence-basis for care in low-resource settings, but also for the evaluation of factors contributing to
effectiveness across multiple dimensions to gain a better understanding of the sustainability, long-term
benefits, and cost-effectiveness of these approaches. The current study will conduct a rigorous evaluation of
an existing program, the Common Elements Treatment Approach (CETA) with women (N=300) who are
mothers of young children (ages 4-6). The trial will take place in the context of an integrated community care
setting in Lima, Peru’s most populous and impoverished district, San Juan de Lurigancho. Our primary aims
are to (1) evaluate the primary and indirect effects of CETA (2) examine moderators of treatment effectiveness,
including implementation quality and neighborhood factors and (3) examine CETA’s cost effectiveness. Our
central hypotheses are that (H1a) CETA will improve women’s mental health, intimate partner violence, and
parenting and that (H1b) CETA will have indirect benefits for women’s economic outcomes and for their
children’s adjustment. We also hypothesize (H2) that effectiveness will be enhanced by strong implementation
quality and the presence of neighborhood promotive factors, and weakened by neighborhood disadvantage.
Hypotheses will be evaluated using an RCT employing a longitudinal design with assessments at baseline
(T1), post-test (T2), 6-month follow-up (T3) and 12-month follow-up (T4). Women will be randomized into the
intervention condition (CETA + Enhanced Case Management [ECM]) or the comparison condition (ECM).
Robust, multi-source (i.e., participant, therapist, supervisor, census data) and multi-method data (i.e., interview,
observational assessment, google street view coding) will be gathered. The contribution will be significant by
advancing research on both direct and long-term benefits of maternal mental health care for family systems,
and is likely to provide important insights into the sustainability and cost effectiveness of these approaches.
The expected outcome is an evidence-based, cost-effective, integrated approach to maternal mental health
care that can be readily implemented by local organizations. Further, we anticipate that learnings from this
project will respond to broader global public health concerns and provide opportunity for cross-context
reciprocal innovation. Expanding the evaluation of CETA delivered in Spanish not only has advantages for the
specific context under study, but provides an important foundation for addressing health disparities in Spanish-
language mental health services in the US as well.

Public health relevance
PROJECT NARRATIVE In many countries, including in Peru, women and children are at disproportionate risk of exposure to adversity, which not only contributes directly to the presence of mental health difficulties (i.e., anxiety, depression and posttraumatic stress), but also may have indirect impacts on the economic and intergenerational well-being of families. This project represents a significant contribution to public health in its evaluation of an evidence- based intervention, the Common Elements Treatment Approach (CETA), with women living in a highly impoverished district of Lima, Peru – San Juan de Lurigancho. The study represents a significant advance in the research literature not only expanding the evidence basis of a previously established program to a new context, but in its unique evaluation of the indirect effects of treatment on intergenerational and economic outcomes as well as moderating effects of implementation quality and neighborhood factors.